STUDY OF HE ROLE OF RNASE IN VIVO IN MODULATION OF ANTISENSE ACTION

The intracellular mechanism of action of exogeneously administered antisense oligonucleotides is not known. Two mechanisms have been suggested based on studies in cell free systems. These are: 1) inhibition of ribosome attachment or movement along mRNA; and, 2) creating a substrate for RNAse H degradation of targeted mRNA. RNAse H is an enzyme which destroys the RNA portion of an RNA/DNA hybrid complex and is present in the cytoplasm of all proliferating cells. Its natural function in cells is unknown. We have obtained a full-length cDNA coding for bacterial RNAse H. We will place this cDNA into a mammalian expression vector which replicates episomally and thus attains high copy number. Cells transfected with this construct and sham-transfected cells will be compared for their responsiveness to antisense oligonucleotide addition. If RNAase H is involved in the intracellular functioning of antisense oligos, then cells with high levels of RNAse H should respond better to addition of these compounds. Likewise, the RNAse H cDNA in reverse orientation in the vector will be transfected in a similar experiment. In this case, endogenous RNAse production should be inhibited (due to this antisense vector) and response to other antisense oligos added extracellularly should be reduced.